2023 Chemical Imaging Gordon Research Conferences

Project Summary
Over the past two decades, a number of advanced chemical imaging platforms have emerged, including
coherent Raman scattering microscopy, transient absorption microscopy, photothermal microscopy, single
molecule imaging, ambient ionization methods for mass spectrometry, electrochemical microscopy, and
imaging with advanced chemical probes. These advances are enabling high speed, high-resolution
spectroscopic imaging of living systems. Applications of these modalities have led to discoveries of
biomarkers defining cancer aggressiveness, drug resistance, and other conditions. Miniaturization of
chemical imaging platforms are enabling on-site clinical investigation of human specimens and in vivo
measurements by endoscopy. Commercialization of various chemical imaging modalities allows broader use
of the technologies. With the mission of bringing together experts in engineering, life science, medicine, data
science, and industrial leaders to foster the growth of this exciting field, the inaugural Gordon Research
Conference (GRC) on Chemical Imaging is to be held at the Stonehill College, Easton, MA from July 30th to
Aug 4th, 2023. A maximum of 175 participants is expected, including discussion leaders, invited speakers,
junior faculty, postdoc and students. Specific aims of the GRC are: (1) Pushing the physical limits and inspire
far-reaching goals. (2) Addressing the most significant problems in biology, materials and medicine. (3)
Promoting fusion of various modalities. (4) Moving the field into new directions and stimulating new horizons.
(5) Engaging and educating young scientists. The chemical imaging GRC aligns well with the mission of the
National Institute of Biomedical Imaging and Bioengineering (NIBIB).

Public health relevance
Project Narrative The inaugural Gordon Research Conference (GRC) on Chemical Imaging, to be held at the Stonehill College, Easton, MA from July 30th to Aug 4th, 2023, aims to bring together experts in engineering, life science, medicine, data science, and industrial leaders to foster the growth of this exciting field. The chemical imaging GRC aligns well with the mission of the National Institute of Biomedical Imaging and Bioengineering (NIBIB): to improve health by leading the development and accelerating the application of biomedical technologies